Roybal Resource and Coordinating Center to Accelerate Translational Aging Research

PROJECT SUMMARY
The overall goal of this Northwell Roybal Coordinating Center to Accelerate Translational Aging Research
(RCC) is to provide strategic leadership, efficient coordination, effective training, and proactive dissemination
for the Edward R. Roybal Centers. We will support Roybal program scientists as they conduct translational
behavioral and social intervention development research relevant to aging and AD/ADRD. Roybal scientists will
advance progress on translational research priorities through the conduct of clinical trials in Stages 0 through V
of the NIH Stage Model for Behavioral Intervention Development. We will provide critical infrastructure for Roybal
Centers to conduct and disseminate scalable, principle-defined behavioral interventions that promote healthy
aging and address the burden of AD/ADRD at multiple societal levels. We will serve as the hub to facilitate and
coordinate trans-Roybal activities, and reinforce the goals of the NIH Stage Model by: 1) providing centralized
administrative support; 2) creating mechanisms for maintaining actively engaged sites; 3) promoting
educational and training opportunities; 4) disseminating scientific advances to all stakeholders; and 5)
evaluating the success of the Roybal program in achieving its agreed-upon goals.
The RCC will serve as the central resource to: 1) share best practices, and ensure scientific integrity and patient
safety for Roybal trials through a centralized Data and Safety Monitoring Board (DSMB); 2) coordinate a
centralized annual Roybal national competition for new trials; 3) host annual meetings; 4) identify joint activities;
5) disseminate study findings and accomplishments to broad and diverse audiences; and 6) evaluate metrics in
achieving program goals. This will be accomplished through a close collaboration with NIA program officers,
Roybal Centers, and other NIA-supported centers and programs. We will leverage and expand upon existing
resources, data management systems, and partnerships to conduct activities that enhance the reach and
impact of the Roybal Centers. Our primary long-term objective is the realization of Roybal scientists’ scientific
productivity, as operationalized by the number of peer-reviewed publications and by the number of
independent grants and contract awards funding NIH stage-informed trials that result from Roybal initial
funding. Our secondary outcome is the visibility of our Roybal scientists’ impact. We will measure visibility
through publication citations, mainstream media impressions, website visits, and social media shares. We
intend that the products of these efforts will offer critical research infrastructure to advance progress on
translational research priorities in accordance with the NIH Stage Model, foster collaboration, and
disseminate to a broad and diverse audience the impact of Roybal scientists.

Public health relevance
PROJECT NARRATIVE This Northwell Roybal Coordinating Center to Accelerate Translational Aging Research (RCC) intends to provide strategic leadership, efficient coordination, effective training, and proactive dissemination for the Edward R. Roybal Centers. All our activities will be focused on reinforcing the goals of the NIH Stage Model and promoting trans-Roybal collaborations.